Principles and Properties of Disordered Regions in Post-Transcriptional Control

Project Summary/Abstract
Intrinsically disordered regions of proteins interact with specific regulatory partners to control gene
expression. Despite their biological importance, we do not understand how molecular features of disordered
regions contribute to distinct regulatory programs because current methodologies cannot interrogate sequence-
function relationships on a proteome-wide scale. This limitation is seen in post-transcriptional control, where
traditional biochemical experiments have identified several disordered regions that recruit translation or mRNA
decay machinery to target transcripts but have been unable to define general rules that govern their function. I
propose to establish a mechanistic framework explaining how the biophysical properties of disordered regions
influence post-transcription regulatory activity by building on an innovative high-throughput approach to uncover
important functional features.
Understanding the molecular principles describing how disordered regions control post-transcriptional
gene expression requires systematically measuring the regulatory effects of many thousands of disordered
sequences. To address this need, I have developed a high-throughput functional assay that couples post-
transcriptional effects to a fluorescent signal and enables large-scale profiling of regulatory activity. This
approach uses a heterologous RNA-protein interaction that tethers a query peptide to a reporter mRNA encoding
a fluorescent protein, whose expression changes based on the regulatory activity of the tethering construct. I
leveraged this assay to catalog functional post-transcriptional regulators in the yeast proteome by expressing a
library of disordered peptides in a reporter strain and used fluorescence activated cell sorting to isolate active
elements, which were identified by deep sequencing. I now propose to learn the molecular grammar of post-
transcriptional regulatory disordered regions by measuring how changes in sequence composition affects activity
using my high-throughput assay. First, I will perform scanning mutagenesis of functional disordered regions and
use my tethering screen to define residues and motifs necessary for activity. Following discovery of regulatory
motifs, I will embed these sequences in different physicochemical environments and examine how local context
influences function. These high-throughput measurements will allow me to uncover correlations between
sequence features and post-transcriptional activity using machine learning approaches. Finally, I will test how
the biophysical properties of disordered regions affect regulatory mechanisms in their endogenous context
through phenotypic analysis and biochemical reconstitution. Taken together, this proposal will establish the
general principles of disordered regions involved in post-transcriptional control by developing and utilizing an
innovative high-throughput functional profiling method.

Public health relevance
Project narrative Intrinsically disordered regions within proteins regulate protein synthesis and mRNA decay to drive development, immunity, and, when mutated, disease. I will interrogate the general features and motifs of disordered regions that control mRNA translation and stability using an innovative high-throughput functional profiling approach. The proposed investigation will provide a molecular framework for how disordered regions regulate post- transcriptional gene expression.